Identity and Accessibility of Immunostimulatory Viral RNAs During Flavivirus Infection

Project Summary
This project aims to reveal the molecular mechanisms underpinning initiation of innate immune activation and
the innate immune response during flavivirus infection. Flaviviruses comprise a number of emerging and re-
emerging pathogens with a global disease burden of over 400 million infections each year. West Nile virus (WNV)
is an emerging neurotropic flavivirus that serves as a model flavivirus and is itself the number one arbovirus
infection in the United States. Infection with WNV elicits a primary innate immune response through activation of
the RIG-I-like receptor pattern recognition receptor signaling pathway when RIG-I detects viral pathogen
associated molecular patterns (PAMP). However, the identity and features of viral RNA (vRNA) that drive this
response as well as how sequestered vRNA is sensed by cytosolic RIG-I remain unknown.
The proposed research aims to identify the species of and molecular motifs within WNV vRNA that drive a
productive innate immune activation and response (Aim 1) and to pinpoint the intracellular sites of vRNA-RLR
interaction in the infected cell to define the relationship between vRNA localization within/outside of viral
replication compartments and innate immune activation (Aim 2). Our preliminary data has uncovered a role for
single-stranded viral replication intermediates (negative-sense vRNA) in driving early innate immune activation.
In Aim 1, cellular subpopulations will be sorted based on innate immune activation status then subjected to RNA
sequencing to further identify specific species of vRNA associated with innate immune activation. Further
analysis of vRNA bound to RIG-I during infection will be performed with immunoprecipitation followed by RNA
sequencing and specific immunostimulatory nucleotides will be mapped via individual nucleotide resolution
cross-linked immunoprecipitation (iCLIP). In Aim 2, novel vRNA-RLR proximity ligation assays alongside
immunofluorescence will be used to pinpoint cellular locations of innate immune activation. Innovative cryo-
electron tomography (cryo-ET) coupled with RNA fluorescent in situ hybridization via correlative light and
electron microscopy (CLEM) will be used to define the relationship between immunostimulatory RNAs and viral
replication compartments at the ultrastructural level.
In addition to revealing the identify and location of immunostimulatory vRNAs during WNV infection, the work
in this proposal will facilitate training in multiple cutting-edge techniques including iCLIP, RNA sequencing and
bioinformatics, and high-resolution imaging including cryo-ET and CLEM, with the support of co-sponsors who
are experts in flavivirology and innate immunity and viral ultrastructure and imaging techniques. Technical and
conceptual training provided will support the transition of the trainee to an independent investigator in RNA
virology and innate immune activation, while research findings will provide conceptual advances in our
understanding of RLR-signaling during flavivirus infection.

Public health relevance
Project Narrative Flaviviruses, including West Nile virus, remain pathogens of global health importance with limited therapeutic or vaccine interventions. Initiation of antiviral immunity is critical for clearance of viral infection and programming of adaptive immunity; however, we currently lack the understanding of types and localizations of viral RNAs that drive productive innate immune activation. This project aims to identify immunostimulatory viral RNA species that trigger RIG-I-like receptor mediated antiviral immunity during West Nile virus infection and define their localization and accessibility in the context of viral replication compartments and cytosolic pattern recognition receptors.